A Mixed Methods Evaluation of Violence, Substance Use, and HIV Risk Among a Vulnerable Population of Male Couples

Project Summary:
A large proportion of new HIV infections occur in the context of primary partnerships among men who have sex
with men (MSM), who are themselves disproportionately vulnerable to HIV, suggesting a need to study factors
that contribute to this disparity. Intimate partner aggression (IPA) and substance use (SU) are two such factors
that are strongly associated with HIV risk behaviors within primary partnerships (e.g., condomless anal sex,
breaks in monogamy/non-monogamy relationship agreements), but despite robust evidence that the effects of
IPA and SU likely overlap in their influence on HIV risk, formative knowledge on how IPA and SU predict HIV
risk in tandem remains missing. This gap in the literature critically limits the foundational knowledge base by
which couple-based interventions (which have shown promise in preventing HIV among MSM) can be
developed, tested, and optimized. The proposed mixed methods research will: a) conduct complex, multi-level
analyses to disentangle the individual, interactive, and dyadic effects of IPA and SU among a large sample of
male couples (Aim 1; N=728 couples), and b) collect qualitative data via in-depth interviews to contextualize
quantitative effects using the lived experience of men in relationships with other men (N=35) experiencing
IPA/SU (Aim 2). Key determinants of risk from quantitative, secondary data analyses (Aim 1) and qualitative,
primary data analyses (Aim 2) will be compared to existing interventions to identify prevention gaps and
formative targets for future development. The research arm of the present proposal is an ideal fit for the NIH
mission since it will document novel pathways to HIV risk among MSM and support future proposals aimed at
translating present findings into novel HIV prevention targets -- a critical next step. Although the applicant
possesses existing foundational competencies in couple research, psychosocial determinants of health, and
advanced quantitative methods, these skills have been accrued via research with cisgender and heterosexual
couples. This fellowship will therefore support her in gaining critical new competencies in HIV research,
qualitative methods, grantsmanship/publication, and sexual and gender minority (SGM) health by releasing her
from grant-related responsibilities currently funding her post-doc appointment. These training and experiential
research activities will imbue the applicant with the tools to grow her program of research among male couples
and advance towards a career as a NIH-funded independent clinical scientist. Northwestern University’s
Institute for Sexual and Gender Minority Health and Wellbeing (ISGMH) is an ideal environment for this
fellowship because of the suite of technical, mentorship, intellectual, and instrumental resources it affords to
early career researchers. Thus, ISGMH and the present proposal will interact to support the applicant in
progressing towards her long-term career goals by providing avenues through which she can gain critical skills,
forge collaborations, seek additional funding, and disseminate findings.

Public health relevance
Project Narrative: Men who have sex with men (MSM) in main partnerships are at disproportionate risk for HIV, and intimate partner aggression (IPA) and substance use (SU) are two such factors that impact HIV risk (e.g., condomless anal sex, breaks in monogamy/non-monogamy relationship agreements) among this vulnerable population. However, the overlapping influence of IPA and SU on HIV risk has not been examined to date, so it is presently unknown whether their concurrent influence might better account for HIV disparities. The proposed mixed methods research seeks to fill this gap by concurrently modelling the effects of IPA and SU on HIV risk using mixed quantitative (N=728 male couples) and qualitative (N=35 MSM in relationships) methods, which will disentangle the individual, interactive, and dyadic interplay of IPA, SU, and HIV risk and provide directions for future innovation around HIV prevention.